Longitudinal Mapping of Network Development Underlying Executive Dysfunction in Adolescence

ABSTRACT
Executive function (EF) undergoes dramatic development during adolescence, and is impaired across
multiple psychiatric disorders such as ADHD and psychosis. Despite this fact, the neural substrates of EF
development remain incompletely understood. Here, we propose to study the development of EF using cutting-
edge techniques from network science. In this proposal, we will recruit 140 participants ages 10-16. This
sample will include 50 with ADHD, 50 with psychosis-spectrum diagnoses, and 40 typically developing
comparators. Using an accelerated longitudinal design, all participants will be followed and undergo cognitive
testing, clinical assessment, and advanced multi-modal neuroimaging at 18 month intervals, yielding an
average of 2.5 sessions per participant. This design will allow us to chart the development of structural and
functional brain networks during adolescence, and delineate how abnormalities of brain network development
are associated with deficits in EF performance, activation, and dynamics. Our overarching hypothesis is that
the development of modular yet integrated brain networks during adolescence allows for specific patterns of
EF activation and dynamics, and represents a fundamental mechanism for EF development. We posit that
abnormalities of network development will be associated with executive dysfunction that is dimensionally
present across psychiatric disorders such as ADHD and psychosis. Accordingly, in Aim 1 of this proposal, we
will chart the longitudinal development of both structural and functional brain networks, and define how
abnormalities of network development are associated with dimensional EF deficits in youth with ADHD and
psychosis. In Aim 2, we will define how abnormal development of brain network topology is associated with
alterations of executive activation and dynamics. In Aim 3, we will integrate high-dimensional imaging data
using advanced multivariate analytic techniques to create a dimensional predictor of executive dysfunction.
Finally, in Aim 4, we will share both raw and processed data, creating a valuable new resource for the
neuroscience community. This proposal capitalizes on complementary skills of the PIs and the research team,
including expertise in brain development, network science, psychopathology, cognitive science, and high
dimensional imaging statistics. Through the proposed multi-level analysis, this innovative research will provide
a substantial advance in our understanding of the neurodevelopmental substrates of executive dysfunction
across psychiatric disorders in adolescence.

Public health relevance
RELEVANCE Executive function is an important domain of cognition that develops rapidly during adolescence, and is impacted by multiple psychiatric disorders including ADHD and psychosis. Greater understanding of how abnormalities in brain network development produce executive dysfunction in psychiatric disorders may be critical for the development of earlier and more effective treatments. This would benefit public health by reducing disability and limiting the costs to society at large.